Contextually responsive implementation of place-activation interventions for promoting physical activity in marginalized urban peripheries in Mexico

Contextually responsive implementation of place-activation interventions for promoting physical
activity in marginalized urban peripheries in Mexico
PROJECT SUMMARY
Background: Mexico is an upper-middle income country with high levels of poverty, inequities, urbanization
(79%), and NCD burden (77% of all deaths), including a major diabetes and obesity crisis. Given this public
health emergency, multiple bold, large-scale evidence-based interventions (EBIs) to improve healthy eating
have been implemented. However, commensurate action for physical activity promotion, another critical
determinant of obesity, diabetes, and multiple other NCDs, remains lacking. Within the context of Mexican
cities, people living in marginalized urban peripheries (low-income neighborhoods on the outskirts of
metropolitan areas) comprise a high-need population with multiple challenges, including limited access to
spaces and programs for leisure-time physical activity. Place-activation interventions are research-proven
strategies (i.e., EBIs) for increasing physical activity in urban settings, by optimizing the use of new or
rehabilitated public open places through community-engaged, multisectoral approaches.
Goal: This proposal seeks to reduce the burden of physical inactivity in Mexico through an urban equity
approach, by increasing the uptake of place-activation EBIs in marginalized urban peripheries.
Methods: We will conduct a mixed-methods study in up to 10 major metropolitan areas of Mexico where our
team has existing partnerships. Our study will test multisectoral engagement methods to advance active
dissemination and implementation (D&I) for increasing the uptake of place-activation EBIs in marginalized
urban peripheries. We will pursue three specific aims: (1) use a mixed methods approach to adapt place-
activation EBIs for use in our study settings (surveys, interviews, and focus groups); (2) conduct a hybrid III
group-randomized controlled trial testing the effectiveness of active D&I methods for improving the reach,
adoption and implementation of place-based EBIs (15 intervention neighborhoods with recent public open
space improvements will receive an active D&I strategy, and 15 comparison neighborhoods with recent public
open space improvements will serve as controls); and, (3) use a community-engaged, participatory approach
to examine the potential for longer-term maintenance and scalability of place-activation EBIs (GIS interviews,
co-creation workshops, concept mapping). Our work will be guided by the “necessity- vs. choice-based
physical activity models” framework for contextually-responsive physical activity promotion in LMICs; and the
adapted version of the RE-AIM D&I framework for scaling up physical activity interventions globally.
Innovations and Impact: This study is innovative and impactful as it will be the first to test state-of-the-
science, active D&I methods for improving the uptake of effective, place-based physical activity EBIs in a high-
need, hard to reach, and underserved population. As such, it will provide critical evidence for addressing the
growing burden of physical inactivity and NCD inequities in Mexico. Further, it will help build urgently needed
capacity for D&I science and physical activity research in Mexico.

Public health relevance
PROJECT NARRATIVE The proposed study is relevant to public health since in Mexico, marginalized urban populations have a disproportionately high physical inactivity and noncommunicable disease burden. It is imperative to identify and deploy effective approaches that improve the uptake of evidence-based, contextually-relevant physical activity interventions in high need areas. A project of this scale can have a profound effect on health inequities in Mexico, and has the potential of informing translation and scale-up of evidence-based urban health interventions in other global settings, including Latino communities in the US.